Microsimulation modeling to support behavioral interventions in AD/ADRD for patients and their caregivers

ABSTRACT The overall purpose of the Roybal Center for Behavioral Interventions in Aging is to strengthen the ability of clinicians everywhere to recommend the safest and most effective treatments for their patients through behavioral economic interventions. The specific aims of the Center are to: (1) Conduct behavioral intervention development and implementation to encourage appropriate medical treatment decisions through the use of behavioral insights from psychology and economics; (2) Inform the selection of these interventions with the greatest potential to impact population health through the use of simulation models, and (3) Translate these findings for policy makers who influence aging policy. The proposed supplemental funding will support leveraging and extending the Future Elderly Model's capabilities for modeling the impact of Alzheimer's disease and related dementias for both patients and their caregivers, in order to identify areas of greatest potential impact. This, in turn, could influence the development and implementation of targeted behavioral interventions. The proposed modeling expansion extends the modeling of behavioral, cognitive, and functional domains, incorporates staging of dementia, and improves the approach to quality of life assessment. Caregiver modeling is enhanced to better reflect care hours and quality of life impacts. This modeling framework then allows for the identification of high-value areas for intervention, be they nudging towards following best practices for prescribing, managing particular patient symptoms, targeting particular populations facing the highest quality- of-life burden, or improving support for caregivers.

Public health relevance
NARRATIVE The Roybal Center for Behavioral Interventions in Aging aims to encourage safe and effective medical decisions through behavioral economic intervention. This supplement will enable the Roybal Center to better develop and implement interventions in high-value areas for those with AD/ADRD and their caregivers.